ATOMIC FORCE MICROSCOPY OF BIOPOLYMERS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The BUSM MS Resource carries out atomic force microscopy to complement mass spectrometry studies of individual biopolymers of high molecular weight, including, e.g., proteoglycans, collagens and molecules having collagen-type domains, and other proteins that contain high levels of glycosylation, as well as non-covalent complexes. AFM is being used to estimate the overall weight and modular composition of such species, on the basis of extrapolations of calibration curves over the range accessible by mass spectrometry. The aim of this project is to use AFM to quickly estimate the MWs of large molecules and complexes as a supplemental tool for mass spectrometry in the high molecular weight range. This is achieved by using AFM to measure the molecular volume of single molecules of known MW as standards, extrapolating a curve using biopolymer standards at different MW, and determining the relation between molecular volume and MW. AFM is also being used to characterize amyloid fibrils, with the goal of relating fibril properties to variations in the amino acid sequence and to posttranslational modifications of the constituent proteins. By using purified patient samples as well as recombinant amyloid proteins, the formation of amyloid fibrils under different conditions and protein/GAG interactions is monitored in both this development project and in several collaborative projects (e.g., Nugent, Skinner, Trinkaus-Randall). AFM images have also been recorded for amyloid fibrils obtained from organ tissues of patients who have succumbed to primary amyloid disease. A manuscript describing recent results will be submitted shortly. To improve resolution in AFM measurements, the use of carbon nanotubes is being explored and a device for mounting the tubes has been constructed and tested. Day-to-day operation, maintenance, training and supervision of the instrument are the responsibility of Dr. Hong, who completed his PhD in the Boston University Dept. of Cellular Biophysics with a focus on AFM studies of mucins.